HABS-HD - Core F - Biostatistics Core

HABS-HD BIOSTATISTICS CORE (CORE F) - ABSTRACT
The overall objective of the Biostatistics Core (Core F) is to oversee data quality control (data QC) and
biostatistical efforts of the HABS-HD U19. Core F will also provide reports for Data Safety Monitory Board
(DSMB) review. These objectives will be accomplished through the continuation and expansion of the
biostatistical resources and functions developed under the ongoing HABS-HD infrastructure now being managed
through a newly established Core F. Core lead, Rema Raman, PhD, is the Director of Biostatistics and
Recruitment for the USC’s Alzheimer’s Therapeutic Research Institute (ATRI). As a biostatistician and a clinical
trialist, she brings decades of experience in study design, data QC, study monitoring and statistical analysis,
having directed Data and Biostatistics Cores and Units for several multi-center clinical research programs in
Neurology. Core Co-lead, Raymond Palmer, PhD is a biostatistician/epidemiologist trained in Preventive
Medicine with over 30 years of experience in Health-Promotion Disease-Prevention statistical research methods
including multilevel design, mediation analysis, and the applications of modern missing data methods. He
specializes in the application of latent variable modeling and longitudinal data analysis within a structural
equation modeling framework, including among diverse populations. Core F includes faculty biostatisticians with
extensive experience in the specialized analyses required for each of the U19 projects. Michael Donohue, PhD,
brings extensive experience in analyzing trajectories of change of Alzheimer’s disease (AD) pathological amyloid
(A), tau (T) and neurodegeneration (N) markers as well as clinical trial design. Drs. Rajesh Nandy, Fan Zhang,
and Zhengyang Zhou have extensive experience in artificial intelligence (AI) and machine learning (ML) methods
for analysis of complex imaging, genomics, proteomics, and metabolomics. Core F Specific Aims: Aim 1: Data
Quality Control (Data QC) (Core – Core Interaction). To ensure highest possible quality of data for scientific
analysis. Aim 2: Biostatistics (Core – Core & Core – Project Interactions). To provide statistical expertise,
consultation and guidance in the design, methodology, execution, and analysis for all HABS-HD Projects. Aim
3: Data Reduction and Discovery (Core – Core & Core – Project Interactions). Collaborate with each Core for
data reduction and novel data discovery analyses. Aim 4: Methods Development & Cross-Study Collaborations
(Core – Core & Core – Project Interactions). To generate innovative statistical methods and collaborate with
investigators in the larger research community.